Mechanisms of RNA and Protein Dysregulations in ALS/FTD Associated with FUS and Ubiquilin 2

Neurodegenerative diseases such as amyotrophic lateral sclerosis (ALS) and frontotemporal
dementia (FTD) are increasing public health challenges, for which effective treatment is still
lacking. At least two major themes have emerged from the studies of ALS/FTD, concerning
etiology related to both RNA metabolism and protein homeostasis. However, the RNA- and
protein-based pathogenesis are likely to be interdependent. Here we propose to unravel the key
molecular pathways in the common pathogenic processes at the intersection of RNA and
protein homeostasis. FUS is one of the RNA-binding proteins that have linked to ALS/FTD.
Recently, we discovered a new role for RNA-binding proteins, as exemplified by FUS, in the
direct regulation of the activities of microRNAs, which are small RNAs functioning as critical
regulators of gene expression. Moreover, considering the notion that FUS protein is capable of
undergoing phase separation, assembling into stress granules, and forming protein aggregates,
and building on our preliminary evidence, we propose to elucidate the previously unrecognized
mechanisms through which aberrant formation of stress granules and protein aggregates
disrupt the RNA homeostasis maintained by ALS/FTD associated proteins. Furthermore, our
studies will be directed at uncovering the cellular quality control systems that are built in to
maintain the RNA/protein homeostasis and understanding how these systems go awry in
diseases. Our unique potential to contribute to this field is both conceptual and technical: We
have developed a unique combination of biochemical/C. elegans/mammalian systems to study
the mechanisms of neurodegeneration, and our recent success bodes well for future plans. The
findings will not only provide novel understandings of the molecular causes of disease for key
ALS genes but also suggest new strategies for harnessing the cellular defense system to
prevent and treat the relevant forms of ALS and other related neurodegenerative diseases. We
predict that the advances gained through our research efforts will eventually lead to new
therapeutic interventions to address these devastating diseases.

Public health relevance
Neurodegenerative diseases are becoming an increasingly relevant public health challenge in our aging society. The mechanisms underlying most of these neurodegenerative conditions such as amyotrophic lateral sclerosis and frontotemporal dementia remain poorly understood. The work in this proposal will elucidate the basic pathogenic mechanisms and the novel regulatory pathways particularly at the intersection of RNA and protein homeostasis, providing much needed insights into understanding specific forms of the neurodegenerative diseases as well as new strategies for developing therapeutic interventions.